Early Childhood Education and Violence Prevention Across the Life Course and Generations

This F31 project seeks to advance the evidence on the violence prevention potential of early childhood
education programs and examine the interactive effects of such programs with multi-level social, economic,
and environmental factors on violence across the life course. In 2020, there were 4.6 million nonfatal violent
victimizations and almost 25,000 homicides in the United States (US).1,2 That year 15.2 million people aged 12
and older reported serious thoughts of suicide, and over 45,000 people died by suicide.1,3 While firearm access
is a significant determinant of violent death,4 risk is also profoundly determined by social and structural
conditions across the life course and inter-generationally, including poverty, early life adversity, and economic
opportunity.5 Despite evidence that sources of risk and resilience begin early in life and accumulate over the
life course and across generations, and that early childhood education can address shared developmental
etiologies of multiple forms of violence, there are critical gaps in our understanding of the long-term effects of
large-scale early childhood education programs on violence.6 This F31 project examines the long-term effects
of Head Start—one of the oldest and largest preschool programs for vulnerable children in the US—on inter-
personal violence perpetration and suicidal ideation, and the social and structural factors that modify those
effects. In Aim 1, we will examine inter-generational effects of Head Start on the second generation’s suicidal
ideation and inter-personal violence perpetration in adolescence and adulthood using a quasi-random variation
in Head Start roll-out over time and place and inter-generationally linked nationally-representative data from
the National Longitudinal Survey of Youth 1979 and Child & Young Adult cohorts. In Aim 2, we will examine
whether Aim 1 effects are modified by offspring sex and race/ethnicity, community disadvantage, and state
policies related to economic opportunity and structural racism. In Aim 3, we will examine the intra-generational
effects of Head Start on handgun carrying and inter-personal violence perpetration in adolescence and
adulthood using data from the National Longitudinal Survey of Youth 1997. In Aim 4 will examine whether Aim
3 effects are modified by participant sex and race/ethnicity, community disadvantage, and state policies related
to economic opportunity and structural racism. All Aims will use targeted maximum likelihood estimation, a
doubly-robust estimator for causal inference with observational data. This project provides the opportunity to
evaluate the effects of a widely implemented program to reduce the toll of violence in the nation. It will
contribute to scholarship on both early childhood education and violence prevention at a time when policy
conversations about violence and its social determinants are increasing in prominence and urgency. This
project will provide the F31 candidate rigorous training in 1) causal inference methods for observational data,
2) quasi-experimental methods for policy evaluation, 3) content expertise in life-course theories of violence and
early childhood education, and 4) social epidemiologic theories for macrosocial conditions and policies.

Public health relevance
PROJECT NARRATIVE Violence is an urgent public health problem which reflects and reinforces social inequities, and high-quality early childhood education programs hold promise in addressing multiple sources of risk and resilience for inter- personal violence and self-directed harm. This project uses nationally-representative longitudinal survey data spanning several decades to estimate the effects of Head Start, a large-scale, comprehensive early childhood education intervention, 1) inter-generationally on suicidal ideation and inter-personal violence perpetration, and 2) intra-generationally on handgun carrying and inter-personal violence perpetration, along with interactive effects of demographic, social, economic, and environmental factors. This project will inform early childhood education and violence prevention policies and support the F31 candidate in developing methodological and content expertise needed to become an independent investigator.